Methods to improve efficiency and robustness of clinical trials using information from real-world data with hidden bias

PROJECT SUMMARY/ABSTRACT
Randomized controlled trials (RCTs) are the gold-standard method of evaluating the safety and efﬁ-
cacy of treatments for diseases, such as cancer and neurological disorders. Due to disease hetero-
geneity, disease rarity, or enrollment disparities, there are limited patients available for clinical trials,
making drug development costly and time-consuming with trials failing at a high rate. The 21st Century
Cures Act has called for regulatory agencies and drug developers to consider innovative clinical trial
designs that bridge conventional clinical trials with real-world data (RWD) to overcome some of these
limitations. External controls (ECs) from RWD have been used to construct the comparator arm in con-
ﬁrmatory trials that eventually received approval from regulatory decision-makers. However, concerns
regarding the validity and comparability of RWD with RCTs have limited their use in a broader context
thus far. Selection bias, differences in variable deﬁnitions, and unmeasured confounding can lead to
biased treatment effect estimates and incorrect inference if RWD are integrated with RCTs. The aims
in this project focus on addressing hidden biases when integrating RWD to improve the efﬁciency of
clinical trials. We will develop a novel sensitivity analysis framework for the use of external real-world
controls to assess the robustness of results to hidden biases, as well as robust and efﬁcient analysis
methods that selectively borrow and adjust for data discrepancies to mitigate the impact of hidden bi-
ases. We will actively engage in dissemination and translation of these new methods to researchers
from industry, academic and regulatory agencies through exemplary applications, state-of-art software,
statistical analysis plan template, resourceful website, and workshops and tutorial sessions. Our ulti-
mate goal is to facilitate more robust use of real-world evidence in regulatory decision-making.

Public health relevance
PROJECT NARRATIVE With technological advancements in healthcare data capture, ﬁt-for-purpose real-world data (RWD) have now been used as external controls to improve the evaluation of safety and efﬁcacy in clinical trials, but such use of external controls is inevitably subject to potential confounding or hidden biases. We will develop a novel sensitivity analysis framework for the use of hybrid external controls to assess the impact of hidden biases, as well as robust and efﬁcient analysis methods that selectively borrow and adjust for data discrepancies to mitigate the impact of hidden biases. User-friendly software packages, statistical analysis plan templates to guide the proposed methods, and applications and case studies using completed clinical trials and RWD will be disseminated to the scientiﬁc community, with the ultimate goal of facilitating a more robust use of real-world evidence in regulatory decision-making.